Stereotyping in medical student decision-making: presence, origins and solutions

Project Summary/Abstract: Many studies have shown that racial and ethnic minorities do not receive therapeutic medical procedures at the same rates as non-Hispanic whites, with the strongest evidence of these racial disparities in the utilization of invasive cardiac procedures. The causes of these racial disparities remain unclear, but geographic and financial access, underlying morbidity, insurance status, and income cannot fully explain the differences. There is suggestive evidence that a contributing factor is a difference in the rate at which physicians offer these procedures to patients based on race and/or gender, and that such biases may be present in medical students. This innovative, multidisciplinary, multimethod study will investigate the prevalence and determinants of racial and gender biases in medical decision-making under conditions of scientific uncertainty of senior medical students. It will further develop information about the dynamics by which non-clinical factors become part of student medical decision-making, and the training environment in which this takes place. In doing so, the study will provide essential guidance to medical educators and developers of cultural competency training who aim to reduce the impact of this social determinant of health and accompanying racial and gender disparities in health service delivery. A nationwide mail survey of senior allopathic medical students will first be conducted to determine the prevalence of such biases using a set of clinical vignettes in which the race and gender of the patient will vary among the sample. The influence of patient race, gender and socioeconomic status on the rates of procedural recommendation by the students will be analyzed. Ecological case studies will then be conducted at each of 14 purposively selected medical schools to explore the context and dynamics of formation of student medical decision-making. Schools for the case studies will be selected based on summaries of response patterns to the survey, with sampling of schools for study that demonstrate greater or lesser degrees of influence of race and gender on their students' responses. In-depth interviews of students, faculty and staff key informant interviews, examination of cultural competency and student curricula and of admission processes are some of the data collection processes that will be used to explore the context in which student decision-making processes are formed, reinforced, or reduced. The findings of the combined survey and case studies will be used to prepare reports for schools, policy makers, and peer-reviewed scientific presentations and publications. The specific objective of this study is to develop and disseminate evidence-based recommendations for medical educators and developers of cultural competency training interested in reducing the role that such biases play in racial and gender disparities in health services delivery.

Public health relevance
Project Narrative: This multidisciplinary study will investigate the prevalence and origins of racial- and gender- based biases in medical decision-making, and make evidence-based recommendations for eliminating these biases. Previous published evidence suggests this understudied social determinant of health is a contributor to health disparities experienced by many in the U.S. __SpecificAimsTextDelimiter__ Specific aims The problem of racial, ethnic and gender disparities in health and health services is a foremost national concern with an ever mounting number of studies demonstrating racial and gender disparities in both health services delivery and health outcomes (1-19). While disparities have been demonstrated in delivery of a wide range of both treatment and preventive care services, some of the most compelling data is in the delivery of cardiac services (20-52). Not only have African-Americans been shown to have lower rates of cardiac catheterization, coronary angioplasty and coronary artery bypass grafting (CABG) than whites, but at least in the case of CABG, these disparities have been associated with increased long term cardiac mortality rates. In attempting to elucidate the causes of racial and gender disparities in health services delivery, researchers have demonstrated that controlling for confounding variables, such as access and pre-existing disease, does not eliminate the observed disparities (20-34,36-37,43,45-47,49,51-52,54-57). There is growing evidence that physician medical decision-making biases based on stereotyping may contribute to the disparities in service delivery, particularly under conditions of scientific uncertainty (57, 65-66, 74-75). One study has also suggested that medical students' perceptions of standardized patients vary depending on the race and gender of the "patient" (77). Despite this interesting observation, there is as yet no data to clarify the extent of racial or gender bias in medical decision making of medical students. Yet this information is important, because if biases in practicing physicians indeed contribute to the causes of observed racial and gender disparities, it is critical to know if their roots extend into early physician training. In an attempt to address the problem of ineffective cross-cultural communication and lack of trust in the physician-patient relationship, cultural competency training has rapidly expanded to the curricula of most of the nation's medical schools. This expansion, however, has preceded a research base on the extent and origins of biases in student medical decision-making, and indeed on the dynamics of formation of medical decision- making processes in medical students. Without this research base, these programs are unable to incorporate training to address what may be a key contribution to the observed disparities. In the absence of research in this area, it is likely that these curricula will continue to be, as they have been to date, largely unable to demonstrate effects on health-related outcomes (90,92). We propose an innovative, multidisciplinary, multimethod study with specific aims to: 1. Quantify the extent of racial and gender based medical decision-making biases among the nation's senior medical students, 2. Describe the context in which medical student medical decision-making processes are formed, comparing schools whose students vary in the extent of decision-making biases demonstrated, and 3. Develop recommendations for admissions &/or training processes to reduce the prevalence of decision-making biases. To accomplish these aims, the investigators will apply a multidisciplinary, multimethod approach, combining a national survey of senior medical students with ecological case studies of 14 medical schools. Results of this study will provide an evidence basis to guide further development of cultural competency training in addressing the role of decision-making biases in racial and gender disparities in health care delivery. The overall goal of this study is to reduce health disparities by focusing on an understudied social determinant of health - racial- and gender-based stereotyping and bias in medical decision-making. We propose to study the role of admissions and training of medical students to identify contributors to reinforcement/formation/reduction of such stereotypes and to develop recommendations for medical educators to reduce or eliminate such bias in medical decision-making.